Influence of developmental programming in adult stem cells and cancer

PROJECT SUMMARY
Maternal obesity is epidemiologically linked to offspring's risk of colorectal cancer (CRC), the third most
prevalent cancer worldwide. In the United States, nearly half the women of childbearing age are obese or
overweight with the trend likely to continue to rise. Along with alarming levels of obesity is the increasing
incidence and mortality rate of CRC in younger populations, suggesting very early exposure may result in later
development and progression of tumorigenesis. To develop meaningful preventative interventions, the
underlying molecular details impacting offspring's risk need to be addressed. Our goal is to determine the
impact of maternal obesity on the transformative risk in offspring by directly assessing the developmental
programming of intestinal stem cells (ISCs), the cell-of-origin for many intestinal cancers, during pre and
postnatal growth. Our aims are predicated on our previous studies from adult mice maintained on a pro-obesity
high-fat Western diet (HFD) in which we determined an increases stem cell numbers, proliferation,
regenerative capacity, and ability to accelerate tumorigenesis. These features are governed by PPAR-delta or
PPAR-alpha, two nuclear receptors orchestrating multiple aspects of lipid metabolism. We established that the
metabolic-transcriptional PPAR axis is necessary to enhance stemness and tumorigenic potential, and also
stabilize the enhanced HFD-induced ISC chromatin state by epigenetic adaptations. We anticipate a similar
program occurs in ISCs from mice exposed to maternal obesity. We posit that naïve exposure to an
obesogenic maternal environment establishes a pro-tumorigenic ground state in offspring's intestinal stem
cells. Using genetically engineered mouse and organoid models, our objective is to distinguish ISC
developmental programming and determine both early intrinsic adaptations and extrinsic environmental
interactions that promote establishment of a stable pre-pathological ISC ground state. Our aims are to: (1)
interrogate the effects and durability of a pro-obesity maternal diet on offspring's colonic stem cell state; (2) test
the requirement and sufficiency of intrinsic lipid mediators in ISC homeostasis and risk of later tumorigenesis;
(3) test the contribution of external inflammatory signaling during ISC developmental programming and
persistent tumor risk. Elucidating offspring's tumorigenic risk distinctly in ISCs established during maternal
dependence is necessary to ascertain how the ISC environment contributes to intestinal homeostasis and
long-term disease risk. This proposal will advance our nascent understanding of the developmental
programming in early life that leads to health and disease disparities in later life.

Public health relevance
Project Narrative In the United States, almost 50% of women of childbearing age are overweight or obese, and the incidence of CRC is increasing in younger populations. We propose that maternal obesity establishes a risk for CRC by exposing offspring to a pro-tumor environment that directly enhances stem cell features and function permitting increased early oncogenic events. We take a genetic and molecular approach using mouse models to dissect the developmental programming and reversibility of tumor risk in offspring from maternal obesogenic conditions.